3/5- Biomarkers to Enhance Early Schizophrenia Treatment (BEEST)

PROJECT SUMMARY
The onset of a first episode of psychosis (FEP) in late adolescence or early adulthood often leads to lifelong
disability. Timing and precision of treatment are of the essence during this critical developmental period.
Unfortunately, FEP patients who do not respond to a conventional first-line antipsychotic (FL-AP) are often
delayed in transitioning to clozapine (CLZ) - or never switch at all - despite the clear superiority of CLZ to FL-
APs in treatment resistant individuals. However, CLZ treatment involves risks of severe side effects, including
agranulocytosis and weight gain. Currently, clinicians and patients currently have no objective, clinically validated
tools to guide this complex decision making in FEP. Our collaborative group has recently published work showing
that a functional brain scan can help predict which FEP patients might not respond to FL-APs, such as
aripiprazole and risperidone. Further, we have shown that a simple genetics test can help predict who is less
likely to gain significant weight, and, similarly, who is less likely to develop agranulocytosis.
We propose to conduct a multi-center, harmonized, randomized clinical trial with the goal of testing whether the
use of biomarkers can lead to better outcomes for FEP patients. The goal of the proposed study is to develop a
clozapine decision support tool based on these biomarkers. First, we will characterize 410 people with an FEP
using three specific biomarkers: a resting state fMRI scan from which we will derive the striatial connectivity
index (SCI) and two genetics tests (one for weight gain and the other for agranulocytosis). Those patients who
are predicted to not respond to FL-APs, and who also have low risk of weight gain and agranulocytosis
(approximate n=180), will be randomized in a triple-blind controlled study to either clozapine or an FL-AP (either
aripiprazole or risperidone) for 12 weeks of treatment. Our main outcomes relate to clinical response, including
positive symptoms, suicidal thinking, and days of hospitalization. We will also perform an MRI at study end to
determine whether functional patterns in the brain distinguish CLZ responders from non-responders (target
engagement). Critically, we are partnering with people with lived experience of psychosis and family members
to help guide us during this trial, and to inform the study design and outcomes; information and choice are
amongst the strongest elements of a successful therapeutic relationship. Overall, our study will evaluate the
efficacy of whether using three biomarkers at the beginning of a first psychotic episode can lead to better patient
outcomes for patients at risk for poor response, by rapidly introducing CLZ rather than waiting for multiple failures
of FL-APs. Our key deliverable would be a clozapine decision support tool, consisting of the three biomarkers
combined with our CLZ dosing strategy for FEP. Such a tool would be a necessary step in the development of
precision psychiatry; if this efficacy trial is successful, a future study would then utilize implementation science
to optimize strategies for dissemination of the decision support tool.

Public health relevance
PROJECT NARRATIVE A first episode of psychosis is a leading cause of disability in young adults, with high risk of suicide and all cause mortality. A substantial part of the burden and cost relates to poor functional outcomes, and the inability to determine the right antipsychotic treatment during the earliest phases of psychotic illness, particularly for those who might need clozapine, a medication that is already known to work best for those who do not respond to conventional antipsychotics. In patients with a first episode of psychosis, the present study aims to determine whether the use of biomarker guided treatment decisions leads to better outcomes and equivalent side effects in people prescribed clozapine compared to conventional antipsychotics, including changes in brain function.